Radical redox catalysis by Ti complexes

Project Summary
This proposal focuses on uncovering new radical-based methodologies that facilitate the synthesis of
bioactive compounds. Organic radicals are highly reactive species with unique chemoselectivities that
complement canonical two-electron chemistry. Recently, the emergence of new reaction strategies that
leverage single-electron redox events and harness radical intermediates for the selective
functionalization of organic molecules has provided chemists with useful tools for solving contemporary
synthetic problems. However, the highly reactive nature of many organic radicals has made it difficult to
impart catalyst-control over the regio- and stereoselectivity of these fleeting intermediates, especially
when complex reaction systems are concerned. In particular, catalytic stereoselective reactions
involving free radical intermediates remain limited, and the discovery of such processes is highly
desirable. To provide new radical-based platforms for reaction discovery and synthetic innovation, we
developed catalytic strategies that leverage the unique redox features of low-valent Ti complexes to
achieve redox-neutral and net-reductive transformations, and through catalyst innovation, we
demonstrated that free-radical-mediated reactions can be made highly enantioselective. These
promising results prompted us to continue to invent novel catalytic and reaction strategies that can
effectively harness radical intermediates and provide powerful tools for solving a wide range of
longstanding synthetic problems. In the parent proposal, we aim to build upon our previous success but
move our research into new grounds. In each of the projects targeted herein, we aim to advance a new
approach that employ radical-based catalysts or reagents to address a prominent challenge in organic
synthesis. The transformations targeted in this grant are either currently unknown or display salient
limitations in reaction scope or selectivity. Among the specific reactions that we aim to develop in the
context of this grant are: enantioselective cycloadditions, enantioselective epoxide isomerizations,
oxidative desymmetrization of alcohols, enantioselective ⍺-oxidation of amides, and site-selective
functionalization of aliphatic C–H bonds. In addition, in-depth studies using canonical physical organic
and electroanalytical techniques will provide insights into the reaction mechanisms. The development
and mechanistic understanding of these proposed transformations will represent significant advances
for the field of organic synthesis.

Public health relevance
Project Narrative To assemble complex molecules rapidly, efficiently, and with predictable outcomes is among the most significant challenges in the discovery of new medicinal agents. This proposal addresses several major technological gaps in the field of organic synthesis, and its successful completion will speed the preparation of novel medicinal lead structures.